Translational Mechanisms of Behavior Change (MOBC) Science

Project Abstract
This is an R13 follow-up to the ongoing conference grant, Roadmap to the Study of Mechanisms of
Behavior Change (MOBC) in Addictions (U13 AA024013, K. Witkiewitz and M. Karno, MPIs) and is in
response to PA-18-648, NIH Support for Conferences and Scientific Meetings. The ongoing U13 project
has been highly successful in achieving its aims, and the MOBC satellite meeting continues to be a centralized
venue for alcohol researchers, MOBC researchers, and cross-disciplinary Science of Behavior Change (SOBC)
researchers to convene, network, and disseminate MOBC science. During the U13 project period, the field has
made significant advances in knowledge regarding MOBC in alcohol and other drug use disorders. Accordingly,
this follow-up application is for continued support of the MOBC meeting. Specifically, we request
funding for three annual, one-day satellite meetings held at the site of the Research Society on
Alcoholism conference. In the proposed iteration, we will continue the important work of the MOBC
satellite while also addressing another area of NIAAA priority: Dissemination, Implementation, and
Translational Science. The application’s specific aims are as follows: 1) To provide a forum for dissemination
and implementation (D&I) and MOBC researchers to identify areas of compatibility in these two fields of study;
2) To provide clear definitional parameters for each field of study as a foundation for building a plan for scientific
integration; 3) To outline methodological guidelines for each field of study, as well as for the emerging field
targeting their integration; and 4) To offer an ongoing venue supporting a diverse group of students, postdoctoral
fellows, and all career-stage researchers in their efforts to push the science of MOBC into key areas of scientific
priority at NIAAA (e.g., D&I; see also NOT-AA-19-010). Consistent with past MOBC conferences, the satellite
meetings will feature an interactive program that the MPIs will create in conjunction with a designated Planning
Committee. Through achievement of its aims, the proposed R13 will provide a unique contribution to NIAAA’s
goal of expanding its MOBC research agenda.

Public health relevance
Project Narrative This R13 Conference Grant will fund three annual meetings to be held as satellite sessions to the Research Society on Alcoholism (RSA). The goal of these meetings is to continue the important work of the Mechanisms of Behavior Change (MOBC) meeting, which has been held annually for the past 15 years at RSA. For the next three years, there will be an emphasis on applying knowledge about behavior change mechanisms to impact direct patient care and broader public health.